Academic Career Skills for Junior Faculty Researchers

PROJECT SUMMARY
Background: Responding to RFA-CA-19-010 for the NCI Awardee Skills Development Consortium (NASDC),
we propose a three-day workshop on research career skills for NCI-funded junior faculty in cancer control and
populations sciences. We have successfully developed and hosted NCI-funded workshops to train early career
investigators in research skills (R25 CA181000). Our proposed NASDC workshop mainly targets two skills sets
listed in the RFA: 1) administrative, managerial, and mentoring skills and 2) leadership and collaboration skills.
However, based on our formative work, we recognized the need to also include training in skills for coping with
the social and emotional challenges of a research career (handling inevitable rejection, balancing
responsibilities, and managing uncertainty of funding). We believe that enhancing all these skills will contribute
to the NASDC goal of helping junior faculty to “maintain long-term productivity in their research careers,
thereby maximizing outcomes from NCI investments.” Approach and setting: The proposed workshop
combines three evidence-based approaches: 1) “mentored mentoring,” directly observed mentoring
opportunities with expert coaching, and career-development lectures from the alumni program of our Workshop
on Research Methods in Supportive Oncology (R25 CA181000); 2) didactics and exercises from the Dana-
Faber Cancer Institute's Leadership Bootcamp for early career faculty; and 3) coping skills drawn from
Acceptance and Commitment Therapy (ACT). ACT may be particularly well-suited to manage the social and
emotional challenges of a research career given its framework of acceptance and moving forward in the
context of personal values. To increase potential collaborations among participants and ensure the provision of
appropriate mentoring expertise by workshop faculty, we will limit participants to cancer control and
populations sciences researchers (behavioral research; epidemiology and genomics; health delivery research;
implementation science; surveillance; and survivorship). The Dana-Farber Cancer Institute (DFCI) will host this
three-day workshop in Boston in collaboration with Massachusetts General Hospital (MGH), another Dana-
Farber/Harvard Cancer Center (DFHCC) institution. Each day of the workshop, participants attend didactic
sessions and meet in small groups for three different mentoring experiences, with coaching from R01-funded
investigators in cancer control and population sciences. We will work with the NASDC Coordinator Center on
the promotion, production, and evaluation of five workshops over three years. Faculty: We have assembled an
outstanding team of experts in cancer control and population sciences (established independent researchers,
grant reviewers, and journal editors) to plan and serve as workshop faculty. As leaders of highly-productive
and well-known programs within cancer control and population sciences at DFCI and MGH, the PIs (Drs. Pirl
and Temel) possess the requisite experience and leadership skills to organize this workshop.

Public health relevance
PROJECT NARRATIVE We propose a three-day workshop on research career skills to address the NASDC goal of helping NCI-funded junior faculty to “maintain long-term productivity in their research careers.” The workshop will enhance skills in leadership, mentoring, and collaborating as well as managing the social and emotional challenges of research.